TASK ORDER 10 - GULF STUDY COHORT MAINTENANCE

This Task Order will support a range of activities related to maintaining the Gulf Study cohort, making full use of the baseline and follow-up data collected to date, and management and oversight of related but separate non-severable tasks focused on extending the exposure characterization of the cohort and developing plans for and administering the second active follow-up of the cohort.